CD8 T cell-dependent pathways leading to immunopathology in cutaneous leishmaniasis

Project Summary
Cutaneous leishmaniasis is a major neglected tropical disease that is associated with clinical manifestations
ranging in severity from relatively benign lesions to chronic highly ulcerated lesions to metastatic disease.
Optimally, drug treatment would eliminate the parasites, but drugs developed to date fail to induce sterile
cure and are often woefully inefficient at controlling the disease. Our new data strongly suggests that
optimal control of cutaneous leishmaniasis requires a response that not only effectively eliminates the
parasite, but also reduces the potential for immunopathology. In a series of publications, we have outlined
the role of CD8 cytolytic T cells in driving inflammation by upregulating the inflammasome and inducing the
release of IL-1. Thus, our studies indicate that an immunopathologic pathway involving the inflammasome
and IL-1 production is a major driver of disease. We further found that blocking NLRP3 or IL-1 in
experimental models of severe cutaneous leishmaniasis ameliorates pathology mediated by CTLs without
blocking protective immune responses, suggesting that either would be excellent targets for host-directed
immunotherapy that could be used in conjunction with conventional anti-parasitic treatments. However,
significant gaps in our knowledge of this pathologic response remain. Here we will utilize a combination of in
vitro and in vivo approaches that will identify the cells undergoing inflammasome activation, determine the
proximal signals that activate NLRP3, and define the chemokines that maintain this chronic
immunopathologic response. To accomplish this in Aim 1 we will determine which cells contribute to NLRP3
dependent pathology during cutaneous leishmaniasis disease progression by defining when
inflammasomes are activated following infection, identifying the cells involved and determining which cells
are required for disease-promoting inflammasome activation. In Aim 2 we will identify the triggers of NLRP3
inflammasome activation in cutaneous leishmaniasis. Finally, we found that the chemokines CCL3 and
CCL4 are associated with treatment failure in patients, and therefore in Aim 3 we will determine if these
chemokines drive the chronicity of cutaneous leishmania lesions by promoting CD8 T cell or regulatory T
cell recruitment to leishmanial lesions. Our proposed experiments have clear translational significance since
they are founded upon substantial data obtained from leishmaniasis patients and are designed to identify
the essential cells and signals required for disease. Such information will allow for a more specific targeting
of immunopathology in leishmaniasis and identify additional targets for host-directed therapies in this
chronic infection. Finally, these studies will be of more general significance, as this pathologic pathway is
not unique to cutaneous leishmaniasis.

Public health relevance
Project Narrative Leishmaniasis is a serious neglected tropical disease where destructive cutaneous lesions develop and treatment is often ineffective. The studies in this proposal seek to define the role of host factors that promote pathology in leishmaniasis and identify new targets for host-directed immunotherapy.